PLANT MOLECULAR GENE ANALYSIS

My research is to better understand how plants respond to environmental, viral and insect stress by isolating and characterizing genes induced during these stresses. Secondly, the expression of plant-encoded as well as other genes in transgenic plants may eventually benefit agriculture.